Studies on Microtubule Binding Proteins

[unreadable] DESCRIPTION (provided by applicant): Kinesins move along microtubules or depolymerize them from the ends. Over the last 12 years, we have used cryo-electron microscopy and image analysis to investigate these motility and depolymerization activities. Based on our findings, as well as work from many other laboratories, we have outlined design principles that unify our thinking about kinesins and myosins and provide a general framework for a mechanistic understanding of these two superfamilies of molecular motors. We now have a good general understanding of the nucleotide-mediated conformational changes underlying processive, plus-end-directed motion by conventional kinesin, non-processive, minus-end-directed motion by kinesin 14s, and many aspects of kinesin 13-mediated depolymerization. Additional work on microtubule associated proteins has provided insights into the mechanisms of selective microtubule stabilization by these proteins. Our past results set the stage for the current proposal. The experiments described here fall into two broad subject areas. First, we describe experiments that will answer what we see as some of the remaining outstanding general questions about kinesin-mediated motility and depolymerization. Second, we build upon our investigations on MAPs, expanding this aspect of our research program and incorporating studies on microtubule plus-end-tracking proteins and kinetochore complexes to investigate the structural basis for modulation of microtubule dynamics and chromosome-microtubule attachments. In all our work, we seek to answer fundamental biological questions and our findings have relevance for both the healthy and diseased states. [unreadable] [unreadable] [unreadable]